Improving Specialty Care Through Virtual Care Models

1 Background: Specialty care deserts—the absence of specialists in geographic regions—have led to an access
2 crisis for the VA. In addition to increasing wait times and causing delays in care, these access needs drive many
3 Veterans to seek care outside VA, resulting in fragmented care, increased risks for hospitalization and hospital
4 readmission, and higher costs. In response, VA has launched the Clinical Resource Hub (CRH) program, which
5 seeks to deliver virtual care from “hub” to “spoke” sites in VA. VISN 21 has begun implementing this model in
6 cardiology at several spoke sites, but little is known about how care utilization and quality within the program.
7 Significance/Impact: This work seeks to better understand the effects of a virtual model of specialty care, in
8 this case cardiology care, on Veterans’ care access and quality. In addition, it aligns closely with several VA and
9 HSR&D priorities, chiefly access to care, virtual care/telehealth, and advancing the goals of the MISSION Act.
10 Innovation: The CRH program and the virtual care model at its core have yet to be studied in depth, and there
11 is no research in progress regarding specialty CRH despite strong interest at the national VA level in
12 understanding how specialty CRH is used and associated outcomes. Given that virtual cardiology care was very
13 limited prior to the COVID-19 pandemic, cardiology CRH is particularly novel. Hence, this project would add to
14 the limited body of research examining virtual cardiology care in the VA. In addition, the proposed work seeks to
15 evaluate this virtual care model at a time of unprecedented choice for Veterans between in-person and virtual
16 care, and limited data on how best to integrate these modalities.
17 Specific Aims: The proposed CDA will offer mentorship and training for me to pursue the following aims:
18 Aim 1. Evaluate quality of cardiology care associated with CRH implementation with administrative data.
19 I will use adjusted difference-in-difference event studies to compare cardiology quality metric achievement for
20 patients who received cardiology care via CRH versus those who received conventional VA-based cardiology care.
21 Aim 2. Assess Veteran perceptions of quality of cardiology care delivered via CRH.
22 I will interview Veterans participating in the CRH program and their caregivers regarding their experiences and
23 perceptions of quality of CRH cardiology care and elicit suggestions for key metrics to focus on for improvement.
24 Aim 3. Construct intervention to track and improve access to high-quality, equitable care through CRH.
25 Building on finding from Aims 1 and 2, I will interview clinicians and employ a facilitated deliberative process with
26 an expert advisory group to construct and pilot an intervention to improve quality.
27 Methodology: In Aim 1, I will use a difference-in-difference event study design to assess the impact of the program
28 on a battery of validated and/or guideline-based quality of cardiology care metrics. In Aim 2, guided by the Fortney
29 model of care access and quality, I will conduct semi-structured interviews of Veterans and caregivers receiving
30 care through the VISN 21 CRH program to understand their experiences with the CRH program and what outcomes
31 they recommend to include in a quality improvement intervention. In Aim 3, I will interview clinicians (Aim 3.1) and
32 conduct a facilitated deliberation process (Aim 3.2) to inform the construction of an intervention (proactive panel
33 management using a clinical dashboard tool) to track and improve quality of care and pilot the intervention.
34 Next Steps/Implementation: To continue moving this research into practice to improve health outcomes for
35 Veterans, I will extend the analysis of cardiology quality of care to compare cardiology care in the community to
36 CRH care. In addition, I will assess the effect of the intervention constructed in Aim 3 on patient outcomes and
37 clinician satisfaction via a hybrid implementation-effectiveness trial. I will continue to work with operational partners
38 to ensure cardiology CRH is improving access to high-quality cardiology care for Veterans. This project supports
39 my goal of becoming an independent VA health services researcher and leader in optimizing cardiovascular
40 disease care access, value, and equity for Veterans through virtual care innovations and implementation.

Public health relevance
1 Specialty care deserts—the absence of specialists in geographic regions—have created an 2 access crisis for the VA. The resulting increased wait times and delayed or fragmented care are 3 particularly dangerous for the many Veterans with cardiovascular disease, making access to high- 4 quality cardiology care especially important. Supported by an HSR&D CDA, I will study an 5 innovative model of cardiology care that aims to address these access barriers with virtual care. 6 To do so, I will work closely with local and national operational partners to study the quality of 7 care associated with this program through mixed methods, then use these insights to construct 8 and test a clinical dashboard for ongoing quality improvement. This project will position me to 9 become an independent VA-based physician-investigator with expertise in improving value, 10 access, and equity in cardiovascular disease care through virtual care innovations.